Piloting a Sequential Multiple-Assignment Randomization Trial to evaluate AllyQuest: an mHealth intervention for HIV-positive young MSM to optimize HIV medication adherence and care outcomes

ABSTRACT In the United States (U.S.), only about a third of HIV-positive young men who have sex with men (YMSM) achieve sustained viral suppression which is crucial for improving individual health outcomes and reducing HIV transmission. Daily adherence to antiretroviral therapy (ART) poses significant challenges for YMSM and is complicated by multiple factors including high levels of depression, substance use, unstable housing, and stigma. Tailored, adaptive interventions are needed that will equip YMSM with the skills, resources, and support networks to face individual, structural, and societal challenges to daily ART adherence. Smartphone- based interventions offer an accessible, customizable, and adaptable platform to improve and sustain adherence. Ally Quest (AQ) is a theory-informed HIV ART adherence and social support application (app) created by a diverse team of behavioral scientists, clinicians, and app developers with input from HIV-positive YMSM. In a small pilot study, higher levels of AQ app usage were associated with significant increases in HIV knowledge and confidence in ability to reliably take ART. The current project will expand the features of AQ to improve intervention engagement and test its feasibility, acceptability, and preliminary efficacy through an innovative Sequential Multiple-Assignment Randomization Trial (SMART) design that evaluates an escalation versus de-escalation approach to intervention intensity. The study will advance mobile Health (mHealth) and medication adherence science via three aims. First, with the guidance of a Youth Advisory Board and HIV care providers, an intensified adherence support feature (AQ+) will be added offering in-app text-based adherence counseling. Second, the feasibility and acceptability of the SMART will be tested through a 6-month pilot study among 60 HIV-positive YMSM age 15 to 24, recruited from U.S. sites participating in the new HIV Adolescent Trials Network. Viral suppression and self-reported ART adherence will be measured at 3-months to determine whether a participant is escalated to a more intensive intervention condition, maintained in their current condition, or de-escalated to a lower intensity condition. Lastly, AQ paradata metrics of participant app usage and participant characteristics will be used to compare the treatment strategies embedded in the SMART to determine optimal intervention engagement approaches for maximizing app use and daily in-app reported ART adherence. This study has high public health significance because YMSM constitute the majority of all new U.S. HIV diagnoses and experience the lowest rates of VS. This application is highly responsive to RFA-MH- 18-605 for mHealth interventions for the HIV continuum of care and the Division of AIDS Research priority focus on high-risk vulnerable populations and behavioral interventions to improve HIV treatment outcomes. Our innovative trial design will inform allocation of care resources to achieve optimal HIV outcomes by characterizing YMSM who are most likely to benefit from a more intensive treatment regimen and determining whether a de-escalation or escalation approach to HIV care achieves better viral suppression outcomes.

Public health relevance
PROJECT NARRATIVE In the United States, HIV-positive young men who have sex with men have suboptimal levels of viral suppression which is crucial for improving individual health outcomes and reducing HIV transmission. Ally Quest is a theory-informed HIV antiretroviral therapy adherence and social support application (app) created by a diverse team of behavioral scientists, HIV clinicians, and app developers with input from HIV- positive young men who have sex with men. The current project proposes to expand Ally Quest and establish its feasibility, acceptability, and preliminary efficacy through an innovative pilot Sequential Multiple-Assignment Randomization Trial (SMART) design that evaluates an escalation versus de-escalation approach to intervention intensity.